A Cohort Study of Preterm Delivery in Relation to Partner Abuse, Mood and Anxiety

DESCRIPTION (provided by investigator): Project Summary/Abstract (Description) Preterm delivery (PTD) continues to be one of the most significant unsolved problems of public health and perinatology. There is increasing evidence that PTD is a complex cluster of problems with a set of overlapping factors and influences. As recently summarized by the Institute of Medicine (IOM) the causes of PTD include individual-level behavioral and psychological factors, environmental exposures, medical conditions, biological factors, and genetics, many of which occur in combination. Members of the IOM expert panel also noted that persistent methodological limitations in previous studies, including treating PTD as a single entity and failure to recognize important common pathophysiological pathways that may lead to PTD (e.g., systematic inflammation, endothelial dysfunction, oxidative stress, and placental ischemia) have hindered discovery of potential treatment and prevention strategies. Previous studies have not rigorously evaluated the independent and joint effects of potent highly relevant social and neuropsychological risk factors of PTD in high risk populations. Increased efforts that integrate interdisciplinary research approaches are clearly needed to understand PTD from biological, clinical, and public health perspectives. The overarching objective of this study is to provide much-needed fundamental information concerning risk of PTD in relation to women's mental health status and exposure to violence before and during pregnancy. We will develop a prospective cohort of 6,000 Peruvian women. We will study the relation of maternal history of childhood sexual abuse, lifetime- and pregnancy-IPV with the prevalence of mood and anxiety disorders (e.g., major depression, minor depression, generalized anxiety and post-traumatic stress disorder [PTSD]). We will also study associations of PTD risk with mood disorder and anxiety disorder early in pregnancy. We will evaluate the extent to which risk of PTD is influenced by alternations in multiple biological markers of maternal neuroendocrine, vascular, and immune status. Finally, we will study the mediational effect of maternal mental health and physiological status in the relation between IPV and PTD.

Public health relevance
PUBLIC HEALTH RELEVANCE: Public Health Relevance Statement (Project Narrative-revised) Preterm delivery (PTD) continues to be one of the most significant unsolved problems of public health and perinatology. There is increasing evidence that PTD is a complex cluster of problems with a set of overlapping factors and influences. Violence against women is a more serious and widespread problem than previously recognized. Results from studies conducted in some countries indicate that 10-52 percent of women report physical abuse by an intimate partner at some point in their lives, and that 10-27 percent of women report experiences of sexual abuse. Mood and anxiety disorders, like intimate partner violence (IPV), are prevalent among reproductive age women, and are risk factors of preterm delivery (PTD) an important determinant of infant mortality. We submit that our research is significant and can make a difference insofar as helping to: (1) identify those at greatest risk (i.e. Among women exposed to IPV, who is at risk for adverse outcomes?) and (2) identify specific targets for intervention (i.e. Should interventions be directed at management of mood or anxiety symptoms in pregnancy? At mitigating neuroendocrine consequences of PTSD? Or at providing anti-inflammatory therapy?). Exposure to IPV is an important risk factor for PTD. However, that knowledge alone has limited practical value because eliminating IPV is probably not a feasible goal for healthcare systems. Our overarching goal, therefore, is to generate new knowledge that can be used to design and implement interventions based in the healthcare system; and to understand pathways from IPV to PTD. These goals are in accordance with those articulated by the Institute of Medicine90 and the recent US Surgeon's General's Conference on the Prevention of Preterm Birth233; and are underscored by the U.S. Congress' passing of the Prematurity Research Expansion and Education for Mothers who Deliver Infants Early (PREEMIE) Act (P.L. 109-450)234. Public Health Relevance Statement (Project Narrative-revised) Preterm delivery (PTD) continues to be one of the most significant unsolved problems of public health and perinatology. There is increasing evidence that PTD is a complex cluster of problems with a set of overlapping factors and influences. Violence against women is a more serious and widespread problem than previously recognized. Results from studies conducted in some countries indicate that 10-52% of women report physical abuse by an intimate partner at some point in their lives, and that 10-27% of women report experiences of sexual abuse. Mood and anxiety disorders, like intimate partner violence (IPV), are prevalent among reproductive age women, and are risk factors of preterm delivery (PTD) an important determinant of infant mortality. We submit that our research is significant and can make a difference insofar as helping to: (1) identify those at greatest risk (i.e. Among women exposed to IPV, who is at risk for adverse outcomes?) and (2) identify specific targets for intervention (i.e. Should interventions be directed at management of mood or anxiety symptoms in pregnancy? At mitigating neuroendocrine consequences of PTSD? Or at providing anti-inflammatory therapy?). Exposure to IPV is an important risk factor for PTD. However, that knowledge alone has limited practical value because eliminating IPV is probably not a feasible goal for healthcare systems. Our overarching goal, therefore, is to generate new knowledge that can be used to design and implement interventions based in the healthcare system; and to understand pathways from IPV to PTD. These goals are in accordance with those articulated by the Institute of Medicine90 and the recent US Surgeon's General's Conference on the Prevention of Preterm Birth233; and are underscored by the U.S. Congress' passing of the Prematurity Research Expansion and Education for Mothers who Deliver Infants Early (PREEMIE) Act (P.L. 109-450)234. __SpecificAimsTextDelimiter__ A. SPECIFIC AIM Preterm delivery (PTD) continues to be one of the most significant unsolved problems of public health and perinatology. There is increasing evidence that PTD is a complex cluster of problems with a set of overlapping risk factors and influences. As recently summarized by the Institute of Medicine (IOM)84 the causes of PTD include individual-level behavioral and psychological factors, environmental exposures, medical conditions, biological factors, and genetics, many of which occur in combination. Members of the IOM expert panel also noted that persistent methodological limitations in previous studies, including treating PTD as a single entity and failure to recognize important common pathophysiological pathways that may lead to PTD (e.g., systematic inflammation, endothelial dysfunction, oxidative stress, and placental ischemia), have hindered discovery of potential treatment and prevention strategies. Previous studies have not rigorously evaluated the independent and joint effects of potent highly relevant social and neuropsychological risk factors of PTD in high risk populations. Increased efforts that integrate interdisciplinary research approaches are clearly needed to understand PTD from biological, clinical, and public health perspectives. The overarching objective of this study is to provide much-needed fundamental information concerning risk of PTD in relation to women's mental health status and exposure to violence before and during pregnancy. We will develop a prospective cohort of 6,000 Peruvian women. We will study the relation of maternal history of childhood sexual abuse, lifetime- and pregnancy-IPV with the prevalence of mood and anxiety disorders (e.g., major depression, generalized anxiety and post-traumatic stress disorder [PTSD]). We will also study associations of PTD risk with mood disorder and anxiety disorder in pregnancy. We will evaluate the extent to which risk of PTD is influenced by alterations in multiple biological markers of maternal neuroendocrine, and immune status (i.e., corticotrophin-releasing hormone [CRH], C-reactive protein [CRP], and interleukin 6 [IL-6]). Finally, we will study the mediational effect of maternal mental health and physiological status in the relation between intimate partner violence (IPV) and PTD. Specific Aim #1. To evaluate, both cross-sectionally and longitudinally, the extent to which maternal exposure to violence, including IPV in early pregnancy, is associated with increased prevalence of maternal mood and anxiety disorders in pregnancy. Hypothesis 1: Maternal history of childhood abuse (any, physical, sexual, , lifetime- and early pregnancy-IPV are associated with a) increased prevalence of mood and anxiety disorders in early pregnancy; and b) increased prevalence of persistent mood and anxiety disorders in pregnancy. Specific Aim #2. To evaluate, both cross-sectionally and longitudinally, the extent to which maternal mood emotional) and anxiety disorders (including depression-anxiety comorbidity) are associated with subsequent increased risk of PTD. Hypothesis 2: a) Maternal mood and anxiety disorders (past year and current) are each independently associated with an increased risk of PTD, b) persistent maternal mood and anxiety disorders (baseline and 3rd trimester), are each independently associated with an increased risk of PTD. Women with comorbid mood-anxiety disorder (e.g., comorbid depression-PTSD) are at particularly high risk of PTD. Specific Aim #3. To evaluate, both cross-sectionally and longitudinally, the independent and joint effects of abuse, particularly IPV in early pregnancy, and mood-anxiety disorders on risk of PTD. Hypothesis 3: a) Maternal experiences with IPV and mood-anxiety disorders in early pregnancy are independent and joint risk factors of PTD; and b) Maternal experiences with IPV and mood-anxiety disorders across pregnancy are independent and joint risk factors of PTD. Women with both exposures are at particularly high risk of PTD as compared with those who are exposed to one or none of the risk factors. Specific Aim #4. We aim to examine, longitudinally, the mediational effects of mood-anxiety disorders, systemic inflammation, and alterations in neuroendocrine status in the linkage between IPV and PTD. Hypothesis #4: Changes in maternal mood-anxiety disorders and biological markers of neuroendocrine and immune status are mediators of relationships between IPV and PTD. This research will be conducted within a low-income urban community where the prevalence of IPV is known to be high63. We will provide critical new information about the role and consequences of IPV on maternal mental health, metabolic status and newborn outcomes. Information will be used to develop, implement, and evaluate interventions that serve to mitigate adverse maternal and perinatal outcomes associated with IPV. Our study is highly innovative in its combined application of, clinical psychiatry, biological, and statistical approaches within an epidemiology research framework. Our results may motivate and justify targeted/strategic public health and clinical investments in improving the physical/mental health and well-being of families, girls, young women, and newborns.